Impact of Microbiota on Alloimmune Responses in Transplantation

PROJECT SUMMARY
The strength of an immune response against a transplanted organ, termed the alloresponse, depends
on the extent of genetic differences between the donor and the recipient and their recognition by the recipient’s
immune system. Our studies from the previous funding cycle have shown that the microbiota, the collection of
microbes that colonize the body and differ between individuals, is an additional novel factor that can causally
modulate the intensity and kinetics of the alloresponse to a transplanted organ. Unlike donor and host genetics,
the microbiota can be manipulated therapeutically, thus providing possible new interventions to protect the graft
and help reduce the need for immunosuppressive drugs that can cause significant side effects.
We initially considered the body’s microbiota as a whole and demonstrated that a reduction in microbial
diversity induced by broad-spectrum antibiotic (Abx) pre-treatment, or an absence of microbiota using germ-free
(GF) mice, both improved minor mismatched skin graft survival. Fecal microbiome transfer (FMT) from control,
but not Abx-pre-treated mice, into GF mice was sufficient to accelerate skin graft rejection. This demonstrated
both the causality of the microbiota on affecting graft outcome, and the divergent effects of distinct fecal microbial
communities. Abx pre-treatment also delayed rejection of fully mismatched skin grafts, minor mismatched lung
grafts, and MHC class II-mismatched heart grafts, indicating that whole-body microbiota affects the outcome of
both colonized and sterile organs. We further showed that that some microbial communities could be dominantly
protective of rejection. This protection was associated with fecal presence of bacteria of the genus Alistipes.
In addition, the half-life of small bowel, lung and skin transplants is much shorter than that of heart and
kidney grafts, supporting the hypothesis that the commensals in the graft may also be able to influence
alloimmunity. Our recent preliminary experiments demonstrate that colonization of donor skin with the single
commensal Staphylococcus epidermidis (S. epi), in the absence of intestinal colonization of the host, can be
sufficient to accelerate skin graft rejection. This result clearly demonstrates that microbiota within the allograft
also impacts graft outcome. Notably, the mechanism by which skin S. epi accelerates skin graft rejection appears
different from how whole-body microbiota in SPF mice or FMT into GF mice accelerates skin graft rejection. We
hypothesize a novel paradigm that the recipient gut microbiota affects immune responses in the whole animal
by systemically modulating DCs up or down, whereas the microbiota in the donor graft locally affects the effector
phase of the alloresponse upon migration of recipient alloreative T cells into the graft. Using a combination of
TCR transgenic T cells and p:MHC multimers to track anti-commensal and anti-donor immune responses in
parallel, as well as select bacterial colonization of distinct tissues in gnotobiotic mice, we will: 1. Investigate the
mechanisms by which gut-only microbes can impact skin graft rejection distally; 2. Define the
mechanisms by which skin-only commensals locally accelerate skin graft rejection.

Public health relevance
PROJECT NARRATIVE The strength of an immune response against a transplanted organ depends on the extent of genetic disparities between the donor and the host. We have shown that the microbiota, the community of microbes that colonize the body, is an additional novel factor that can modulate this response. We will investigate both how microbial location in the body differentially impacts transplant outcome, as well as delineate the mechanism by which select taxa either promote or delay transplant rejection.